THE DEVELOPMENT AND FUNCTIONAL NEURAL NETWORK OF FLEXIBLE RULE USE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study is to investigate the development of the mechanisms and neural systems involved in flexible rule use from middle childhood to adulthood.